DEVELOPMENT AND EXPANSION OF BIOMEDICAL SCIENCES IV

The objectives of Phase III of the Development and Expansion of Biomedical Sciences at Meharry are: 1. To continue the improvement of the training effectiveness of the Graduate School of Meharry. 2. To extend the areas of training in the biomedical sciences available to students at Meharry. 3. To increase the extent of student involvement both at the undergraduate and the graduate level. These objectives will be accomplished by providing direct support of: 1. Research projects in the Departments of Biochemistry, Microbiology, Pathology, Pharmacology, Physiology, as well as in the Division of Biomedical Sciences. 2. The research in Biomedical Sciences (RIBS) Program with its focus on undergraduate students. 3. Increased number of graduate students. Both individual discipline-oriented research projets, as well as team-oriented projects are presented.